Development of Face Perception: Cross-sectional and Longitudinal Investigations

The ability to recognize faces, which is critical for everyday social interactions, improves from childhood
to adulthood. In adults, face recognition is mediated by a series of regions in the ventral aspect of human occipital
and temporal cortex, constituting the ventral face network. The selectivity and spatial extent of the ventral face
network develop from childhood to adulthood, in correlation with age-related improvements in face recognition.
However, the neural mechanisms of this development, the rate of development, and the relation among factors
that govern this development are not well understood. The goals of the proposed research are to fill these
substantial gaps in knowledge by determining the relationship between anatomical and functional brain
development and understanding how these developments ultimately lead to improved behavior. To achieve
these goals, the research will combine cross-sectional and longitudinal measurements in children (5-10 years
old) and adults (23-28 years old) obtaining innovative multimodal measurements of functional magnetic
resonance imaging (fMRI), quantitative MRI (qMRI), diffusion weighted imaging (DWI), and behavior in each
participant. Aim 1 will employ longitudinal measurements of fMRI, qMRI, and face recognition behavior to
determine what is the rate of the development of gray matter and functional selectivity in the face network, if
development of gray matter and function occur together or one precedes the other, and if neural developments
correlate with behavioral improvements in face recognition. Aim 2 will employ cross-sectional and longitudinal
measurements using fMRI, DWI, qMRI, and behavior to determine if and how white matter properties of the face
network develop, if white matter developments are linked with either functional or behavioral development, and
if development of white matter and function occur together or in sequence. Aim 3 will use fMRI and population
receptive field (pRF) modeling to determine if and how pRFs in the ventral face network change from childhood
to adulthood, and if development of pRF properties is related to fixation patterns on faces. Aim 4 will test if neural
responses in face-selective become less sensitive to face transformations from childhood to adulthood,
consequently improving generalization across different instances of the face under different sizes or views.
Critically, in each aim we will examine not only the development of the ventral face network but the development
of the human ventral visual stream more broadly to elucidate the specificity of developmental effects. Overall,
the proposed research will advance understanding of neural mechanisms underlying the development of face
recognition, it will elucidate completing developmental theories regarding the relation between anatomical and
functional brain development, and will provide the first measurements of the developmental rate of multiple facets
of human ventral temporal cortex anatomy and function. This research will provide an essential basis for future
research on typical and atypical conditions including developmental prosopagnosia, Williams Syndrome, and
autism.

Public health relevance
Project Narrative Our proposed research is in-line with the NEI’s mission to advance knowledge of mechanisms of visual function, development, and disorders. We propose detailed investigations of multiple anatomical and functional aspects of development of the human ventral visual stream face and their impact on visual recognition. We expect that our proposed research will break new ground in understanding the development of neural mechanisms underlying face recognition, and high- level vision more generally, providing an essential base for future research on developmental disorders involving altered visual and facial processing, such as congenital prosopagnosia, Williams Syndrome, and autism.